Pathogenesis and Treatment of NUT-Midline Carcinoma

Project Summary Abstract. NUT midline carcinoma (NMC), with a median survival of 6.7 months, is one of
the most aggressive solid tumors known. It is a subtype of squamous cell carcinoma characterized by
translocation of the NUT (aka NUTM1) gene, most commonly forming a fusion to the double-bromodomain
encoding protein (BET), BRD4. There is an urgent need for the identification of more specific therapeutic
targets in NMC. The over-reaching goal of this proposed project is to greater understand the mechanism of
BRD4-NUT oncogenesis and identify effective therapeutic targets for treating this disease.
BRD4-NUT functions to block differentiation and maintain proliferation of NMC cells, largely through
activation of MYC expression. This function is disrupted upon treatment with BET inhibitors, which as acetyl-
lysine mimetics prevent binding of BRD4 bromodomains to acetylated chromatin. BRD4-NUT drives the
expression of pro-growth target genes, including MYC, through the formation of megabase-sized massive
hyperacetylated 'megadomains'. BRD4-NUT megadomains arise from pre-existing active enhancers and
spread to fill cell-type-specific topologically associating domains (TADs). TADs are higher order genomic
structures whose function is to orchestrate cell-fate determining transcriptional programs through DNA-DNA
contacts. Unique proteins recruited by BRD4-NUT recently identified by our group include the histone acetyl-
transferase (HAT), p300, and several ZNF proteins collectively termed Z4. These findings indicate that BRD4-
NUT ‘hijacks’ cell-type specific TADs to drive transcription of pro-growth, anti-differentiative genes as
postulated in the following model: First, BRD4-NUT complex proteins seed regions corresponding to cell-type-
specific active TADs through the chromatin-binding of BRD4. Second, megadomains form from contiguous
expansion of BRD4-NUT complexes across chromatin in a feed-forward manner dependent upon p300 HAT
activity. Third, megadomain size is limited by TAD boundaries and HDAC activity recruited by the Z4 complex.
Fourth, hyperacetylated chromatin, recruitment of chromatin remodelers, and upregulation of cis lncRNAs
changes the chromatin configuration to enhance DNA-DNA interactions to drive transcription of key pro-
growth, anti-differentiative genes. The goals of this proposal are to test this hypothetical model, as listed in the
specific aims below.
Aim 1. To determine how BRD4-NUT megadomains form.
Aim 2. To determine how BRD4-NUT megadomains function.
Impact. Successful completion of the aims is expected to identify key BRD4-NUT-associated proteins in
pathologic megadomain formation, and will identify novel and possibly more effective therapeutic targets in
NMC and other cancers. In addition, we predict that BRD4-NUT megadomains will provide a model with far-
reaching impact on the structure-function relationship of chromatin conformation in cancer and development.

Public health relevance
Principal Investigator/Program Director (Last, First, Middle): French, Christopher, Alexander Project Narrative NUT midline carcinoma is an incurable highly aggressive cancer with a median survival of 6.7 months. The causative oncoprotein, BRD4-NUT, drives aberrant oncogene target expression through formation of megabase-sized contiguous BRD4-NUT and acetyl-histone enriched chromatin, termed megadomains. The project, which is to determine how megadomains form and function will reveal fundamental principles of how chromatin conformation can be manipulated in a novel cancer mechanism, and identify novel therapeutic cancer targets. PHS 398/2590 (Rev. 09/04) Page Continuation Format Page